New techniques for detecting and handling nanocrystals for cutting edge structural biology methods

Project Summary
Determining the detailed structural characteristics of biomolecules relevant to human health and disease
is one of the most crucial tools in our arsenal for understanding disease etiology and mechanism, and for
being able to develop new therapeutics that target these molecular entities. There are new techniques in
structural biology, including serial femtosecond crystallography, serial synchrotron crystallography, and
microcrystal electron diffraction, that have the potential to greatly advance structure determination of
biomolecules and to empower access to structural details that have deﬁed characterization via other
structural methods. These new structural methods all rely on being able to generate, detect and
appropriately handle extremely small crystalline samples of biomolecules. This requirement for sub-
micron sized crystals is one of the key features of these technologies, and presents a major obstacle
to the advancement of these methods for structure determination. This proposal presents innovative
technologies for both image analysis and sample handling expressly designed to address the speciﬁc
challenges of working with submicron crystals. We plan to use nonlinear optical microscopy methods
coupled with purpose-built application of point process modeling and wavelet image analysis approaches
to provide computational tools needed to enable detection and characterization of submicron samples
that are invisible to the brightﬁeld microscopy tools that are typically used in sample generation and
experimental set up for crystal based structural biology. In addition, we will examine different ﬁxed target
platforms to reduce sample handling, minimizing potential crystal damage, as well as test use of acoustic
droplet ejection techniques for nanoliter volume sample transfer. These innovations will be a powerful
addition to structural biology toolbox for leveraging the cutting edge diffraction based methods currently
available for structure determination. These technology developments will break through key barriers to
the widespread use of these cutting edge structural methods.

Public health relevance
Project Narrative Structural characterization of biomolecules important in human health and disease is crucial to under- standing how these molecules function, as well as to designing therapeutics. Structural methods that make use of vanishingly small crystals have the potential to revolutionize how we obtain highly detailed structural `snapshots' of biomolecules. This technology development proposal will enable fundamen- tal advances by developing pipelines for enhanced detection, imaging, and sample handling to enable these structural methods, accelerating our understanding of the molecules involved in many diseases and biological processes.